PROBE DELIVERY CORE

Fluorescent protein biosensors have grown into one of the most powerful tools for the study of cell biology. When combined with intravital microscopy, these biosensors have the potential to sensitively interrogate molecular, physiological and physical events occurring within living cells In the most relevant, in vivo setting. However, the utility of fluorescent protein biosensors for in vivo study has been limited by the difficulty of in vivo gene delivery, largely restricting their application to studies of cells in, or derived from transgenic animals, in order to realize the potential of fluorescent biosensors for studying cell biology in vivo, flexible methods of in vivo gene delivery must be developed. The goal of the Probe Delivery Core is to develop and characterize simple, inexpensive and effective methods for expressing fluorescent biosensors In the rodent kidney and to provide these methods to end-user investigators in the form of fully characterized probes and detailed protocols for the use of these probes and for the development of new probes. These probes will provide renal researchers with powerful new tools that will enable them to conduct novel intravital microscopy studies addressing fundamental issues of renal physiology, cell biology and pathophysiology.

Public health relevance
The Indiana O'Brien Center is founded upon the mission of developing and implementing methods of microscopy that provide unique and powerful insights into renal function and dysfunction. The Probe Delivery Core will play a critical role in this mission, developing techniques and reagents to support the delivery and expression of novel biosensors that will support unique microscopy studies.